Mitochondrial Mechanisms of Astrogliosis in Epilesy

Project Summary
Neuroinflammation has been identified as a therapeutic target for acquired epilepsy. However, if and how
mitochondria contribute to neuroinflammatory processes such as astrogliosis remains unknown. The goal of
this proposal is to determine if mitochondrial reactive oxygen species (mtROS) generated within neurons can
activate astrogliosis. This non-cell autonomous regulation is hypothesized to occur by posttranslational redox
modification of glial fibrillary acidic protein (GFAP) resulting in long-lasting neuroinflammation and epilepsy. To
test this idea, we plan to utilize a combination of tools and approaches including embryonic and inducible
mouse models lacking mitochondrial superoxide dismutase in forebrain neurons, 2-photon imaging of
astrocytic calcium, mitochondria-specific models, and mass spectrometry. The following specific aims will be
explored. Specific Aim 1: Determine if mitochondrial oxidative stress is sufficient to increase astrogliosis in
vitro. Specific Aim 2: Determine the role of neuronal mtROS in GFAP upregulation and astrogliosis in vivo.
Specific Aim 3. Determine the role of mtROS in GFAP upregulation, astrogliosis, epilepsy and/or cognitive
dysfunction in chemoconvulsant epilepsy models. Potential clinical application of the proposal includes
identification of novel metabolism-based therapies to target astrogliosis in epilepsy.

Public health relevance
Project Narrative This proposal will explore the role of mitochondria and oxidative stress in astrogliosis associated with acquired epilepsy. The major goal is to investigate the role of mitochondrial redox processes in initiating seizure-induced astrogliosis. The studies can have a sustained impact on the field and result in novel metabolism-based therapies to control neuroinflammation in epilepsy.